Environmental Predictors of Treatment Responsiveness for Pediatric Acute Asthma Exacerbations

PROJECT SUMMARY
Acute exacerbations are the primary cause of morbidity and mortality among children with asthma. Current
treatment for acute asthma exacerbations in the pediatric emergency department (ED) follows a “one-size-fits-
all” approach, including inhaled bronchodilators and systemic corticosteroids. However, treatment response to
initial protocolized therapies is variable and unpredictable presenting a significant management challenge for
ED clinicians. The factors driving the heterogeneity in ED treatment response are poorly understood, which
has impeded accurate prediction of treatment response, development of effective therapeutics, and advances
in ED asthma management. Thus, there is a critical need to better characterize the factors driving treatment
response to inform precise ED treatment strategies for asthma exacerbations. We have found that almost all
ED asthma exacerbations are associated with a respiratory virus and that specific viral species influence ED
treatment response. However, the role of nonviral causes of asthma exacerbations, such as outdoor air
pollution and environmental allergens, are less understood. These critical environmental factors are strongly
associated with asthma exacerbation occurrence and severity, but their impact on treatment response remains
unknown. This R03 application proposes a proof-of-principle study to investigate the role of outdoor air
pollution and environmental allergens in driving treatment response in children with asthma exacerbations in
the ED. Leveraging robust clinical data and banked biosamples, we will determine the association between
outdoor air pollutant exposure (Aim 1) and aeroallergen sensitization (Aim 2) and acute asthma exacerbation
treatment responsiveness in the ED. This work builds on the PI’s K23 findings and will provide critical
preliminary data for a multicenter R01 application aimed at validation of a comprehensive clinical prediction
rule incorporating environmental, biologic, and physiologic predictors to differentiate ED treatment
responsiveness early in the ED course. An effective prediction rule will improve outcomes by guiding clinical
decisions and facilitating timely and appropriate therapeutic interventions and disposition decisions. This work
represents a paradigm shift in the ED by moving from a “one-size-fits-all” to a personalized, phenotype-
directed approach for the management of asthma exacerbations.

Public health relevance
PROJECT NARRATIVE Childhood asthma exacerbations account for over 750,000 emergency department (ED) visits annually and present a significant management challenge for clinicians due to the variable and unpredictable response to emergent rescue therapies. This proposal investigates the role of outdoor air pollution and environmental allergens in driving ED treatment response for children with asthma exacerbations and will provide critical preliminary data for a R01 study aimed at validating a robust clinical prediction rule incorporating environmental, biologic, and physiologic predictors to differentiate treatment responsiveness early in the ED course. This work will advance ED management towards a personalized, phenotype-directed approach to guide clinical decisions, facilitate timely and appropriate therapeutic interventions, and improve clinical outcomes for children with asthma exacerbations.